Animal Food Regulatory Program Standards Implementation Maintenance, with Mutual Reliance Initiatives

PAR-25-003: PROJECT SUMMARY – Overall Component
The objective of this multi-component project is to support and advance efforts for a nationally
integrated human and animal food (HAF) safety system through the maintenance of the Animal
Food Regulatory Program Standards (AFRPS) and continuous improvement of Washington
State Department of Agriculture’s (WSDA) Animal Feed Program. Through these initiatives, the
program will compel mutual reliance between the state and federal partners, reducing
duplication of efforts. WSDA will continue its conformance with current and future versions of
the AFRPS and Preventive Controls of Animal Food (PCAF) which encourages safe animal food
and promotes compliance with regulations.
This project will ensure AFRPS is sustained and will maintain the staff needed for project
deliverables; such as standardized processes and procedures for training, inspections,
compliance and enforcement, and auditing. The program will assist in completing
comprehensive full-scope inspections according to established frequencies and prioritizing high-
risk firms in workplanning.
In addition to maintaining the core regulatory and response foundations that have been
established through AFRPS, WSDA plans to initiate Mutual Reliance objectives to continue
identifying and strengthening integral professional relationships between HAF safety partners
including Federal, state, local, and tribal stakeholders in the public health, agriculture,
regulatory, laboratory, industry, academic, and emergency response arenas.
Enhanced electronic communication and cooperative enforcement will support Food Safety
Modernization Act (FSMA) overall goals of food safety, mutual reliance and efficient work
planning while supporting the Animal Feed Program’s mission to regulate the safety and
integrity of animal food, to protect animal and public health, and ensure market fairness.
Through this multi-modal approach, WSDA anticipates the ability to contribute to an integrated
food/feed safety system in a standardized and efficient manner to better protect the public
health of Washingtonians, animal health, and the U.S. population as a whole.

Public health relevance
PAR-25-003: Animal Food Regulatory Program Standards Implementation and Maintenance, with Mutual Reliance Initiatives (U2F) PROJECT NARRATIVE This project intends to improve the nationally integrated human and animal food safety system through maintenance of the Animal Feed Regulatory Program Standards (AFRPS), food/feed Rapid Response Team, and Mutual Reliance Initiatives in Washington state. These project components advance efforts for a nationally integrated food safety system by encouraging the safe manufacturing and processing of animal food, efficiently and effectively responding to animal food safety events, and increasing communication and collaboration with federal partners. Through continued innovation, standardization, and partnership between stakeholders both internal and external to the agency, the Washington State Department of Agriculture Animal Feed Program intends to work toward continually improved animal food safety and thus improved public health protection both within Washington State and nationally.